NIAID- VRC - PREMISE - Pandemic Response Repository through Microbial and Immunologic Surveillance and Epidemiology

One of the key components of the VRC mission involves the rapid advancement of promising vaccine and therapeutic candidates from the laboratory to the clinic. There is a need for supporting translational research leading to identification of new therapies or approaches in treating and preventing infectious diseases. PREMISE has been developed as a Pandemic Response Repository through Microbial and
Immunologic Surveillance and Epidemiology, and provides detection and surveillance of novel and
emerging pathogens and deep
analysis of host immune responses at a population-wide scale in order to prepare for an effective response to infectious threats.